Arsenic Exposure and its Association with Cancers among Residents with Wells in New Mexico's Border Counties

PROJECT SUMMARY. Inorganic arsenic is a known carcinogen and toxic chemical. Arsenic contamination in
drinking water is an environmental public health concern in the United States (US) and worldwide. Almost 43
million, or 15%, of all US residents, depend on private or domestic wells as their exclusive source of drinking
water. State and/or Federal agencies do not regulate domestic well water safety and quality. Instead, consumers
are responsible for monitoring their water safety and quality. In New Mexico (NM), naturally occurring arsenic
concentrations in drinking water are considered among the highest in the US. Of the 33 counties in NM, Doña
Ana County, one of the border counties in NM, has the highest average arsenic concentration, exceeding the
Environmental Protection Agency Maximum Contamination Level of 10 µg/L. This project will focus on rural,
underserved counties along the NM-Mexico border, including Hidalgo, Doña Ana, Otero, Lea, Eddy, and Luna,
with residents who have well in their households. The NM-Mexico six border counties reported an alarming
incidence of 5,366 new age-adjusted arsenic-associated cancers per 100,000 population during the period 2016-
2020. Doña Ana County has the second-highest cancer incidence in NM. Rural people who live in NM-Mexico
border counties are underprivileged with lower socioeconomic status and are unaware of arsenic toxicity on
health. While the link between arsenic exposure and cancer burden is a nationwide issue, there is a simultaneous
need to protect and prevent arsenic-related cancers due to the long latency period to develop cancer in rural,
underprivileged people in southwestern border areas. A promising approach to examining links between arsenic
contamination and cancer lies in urine biomarkers. In particular, 8-hydroxy-2'-deoxyguanosine (8-OHdG), F2-
isoprostane, and 4-hydroxyneonal (4-HNE) lipid adducts are biomarkers for DNA damage and oxidative stress
and can initiate cellular damage that leads in the carcinogenic pathway. Our collaborative research team of metal
toxicity and carcinogen experts will detect metal-contaminated water and then identify the presence of
biomarkers and arsenic in urine samples from 125 well-water-dependent adults in the six NM-Mexico border
counties. Self-reported and doctor-diagnosed cancer history information provided by the participants will be used
to track the cancer burden among arsenic-contaminated, well water users. This project will use the urinary
arsenic, 8-OHdG, F2-isoprostane, and 4-HNE biomarkers to identify arsenic contamination; the presence of
arsenic, DNA damage, oxidative stress, and cellular mutation; and arsenic-related cancer burdens in the rural
underprivileged populations living on arsenic-contaminated well water in border counties at NM. This project will
help students, including underrepresented groups in biomedical sciences, gain high-quality, hands-on research
experiences in the execution, analysis, and reporting of a research study as guided by the PI. This project will
significantly impact the PI, an early stage and new investigator, and allow to generate data to aid in more
extensive federal grant proposals submitted in the future.

Public health relevance
PROJECT NARRATIVE. Consumption of arsenic-contaminated water is associated with an increased risk of lung, hepatobiliary, bladder, kidney, ureter, prostate, breast, and uterine cervix cancers. This project aims to achieve three main objectives: 1) Assess arsenic contamination in rural New Mexico water wells; 2) Identify DNA damage (8-hydroxy-2'- deoxyguanosine) and oxidative stress (F2-isoprostane, 4-hydroxyneonal) biomarkers through urine samples; and 3) Determine arsenic levels in urine specimens of residents from the rural underprivileged New Mexico- Mexico border population, who rely on water for domestic use. The study will investigate the link between arsenic- contaminated well water and the development of associated cancers within this population.